P and F Program

PROJECT SUMMARY: PILOT AND FEASIBILITY PROGRAM
The C-SiG Pilot and Feasibility (P/F) Program is vital for helping us attract new investigators to
digestive disease research. The P/F Program provides investigators with sufficient funds to obtain
robust preliminary data to be used in research grant applications awarded by external agencies,
especially NIDDK. In addition to research funding, P/F awardees are mentored by the C-SiG
Leadership and are provided career development opportunities through the C-SiG Enrichment
Program. Thus, the P/F program allows C-SiG to foster and strengthen the pipeline of new
investigators engaging in digestive disease research.
The primary goal of the C-SiG P/F Program is to support new investigators (Type N) just
beginning their careers in digestive diseases research. Proposals are also accepted from established,
funded investigators who are new to digestive disease research (Type EN) who wish to test the
applicability of their expertise to a digestive disease-related problem. The P/F Program typically
funds up to four outstanding proposals each year for a total of $100,000 per year. Since 2009
when C-SiG began, the P/F Program has received an average of 9 applications each year, and
funded 26 investigators (25 Type N ,1 Type EN, 0 Type E) with first year awards ranging from
$25,000-$40,000 (average award $30,000) in direct annual costs per year. Additionally, P/F recipients
are eligible to compete for a New Supported Investigator Award that provides a second year of
funding (up to $50,000) to one P/F Award recipient who has made exceptional progress during their
first year. Since 2009 when C-SiG began, 7 Named Supported Investigator Awards have been given
to meritorious P/F projects to provide a second year of funding (average award $39,000 per year
[range $20,000-50,000; total $275,000] provided by Mayo). As of May 2018, 19/26 (73%) P/F award
recipients have achieved independent Federal funding.
A detailed and rigorous peer review process has been developed to select projects of the highest
quality. Built in this process is a mechanism to provide detailed constructive criticism to all eligible
applicants, including the unfunded ones. The following sections detail the eligibility requirements, the
mechanisms used to announce program funds, the application process and mechanisms for scientific
review, and the mechanisms for program oversight and review.